Biophysics Core

ABSTRACT, CORE 3
Biophysical methods, such as single-molecule techniques, quantitative imaging/spectroscopy and native mass
spectrometry (nMS) are powerful tools to gain mechanistic insights into key dynamic interactions and processes
occurring during the early and late steps of the HIV-1 lifecycle. The goal of Core 3 (Biophysics Core) is to provide
requisite instrumentation, expertise and training to augment the B-HIVE capabilities across all three center
projects by enabling cutting-edge studies of protein-protein, protein-nucleic acid and protein-membrane
interactions in living cells and in model systems. To accomplish these goals we will: (1) Provide advanced
fluorescence microscopy capabilities to visualize early and late events of the HIV life cycle (Melikian); (2) provide
advanced capabilities in single-molecule biophysics to probe dynamics of proteins, nucleic acids and their
complexes (Millar & Musier-Forsyth); and (3) provide methods for biophysical characterization of
macromolecular complexes (Musier-Forsyth and Wysocki). A critical part of the Core 3 mission is training the
users remotely or in person, through visits to the labs of the Core co-leads, workshops and videoconferences.
To accomplish this goal, the core will provide basic imaging, single-molecule and nMS services using established
pipelines to all B-HIVE projects, as needed, implement advanced techniques and engage in long-term projects
through collaborative efforts with the B-HIVE investigators, and develop novel technologies in response to the
needs of Projects 1-3.